MDM2 inhibitor therapy for TP53 wild-type GBM

Project Summary – Project 2
Disruption of tumor suppressor p53 function is the most common alteration in cancer and results in
dysregulation of DNA repair following genotoxic insults. Use of small molecule inhibitors blocking the
interaction of p53 with murine double minute 2 (MDM2) prevents MDM2-mediated degradation of p53 and is
the most clinically advanced strategy to target this critical DNA damage response pathway. In this project, we
introduce the highly potent MDM2 inhibitor BI-907828 as a novel therapeutic approach against glioblastoma
(GBM). This best-in-class MDM2 inhibitor is highly potent in vitro in GBM PDXs at single-digit nanomolar
concentrations. BI-907828 monotherapy has significant anti-tumor activity against orthotopic GBM PDXs with
corresponding robust evidence of on-target pharmacodynamic drug effects – stabilization of p53 and increased
p53-mediated transcription of pro-apoptotic genes. Further, combined therapy with BI-907828 and radiation
markedly enhances induction of pro-apoptotic genes in both the extrinsic and intrinsic apoptotic pathway, and
combined radiation/BI-907828 therapy in orthotopic PDXs results in profound extension of animal survival in
two GBM PDXs. This activity in orthotopic PDX models known to have an intact blood brain barrier is
especially interesting since BI-907828 has relatively limited distribution into normal brain. In contrast to
modulation of mitogenic signaling or many other DNA repair targets, which require sustained, high-level
suppression of optimal effects, MDM2 tightly regulates p53 stability in a negative feedback loop. Thus, we
hypothesize that even short-term inhibition of MDM2 activity can lead to increased expression of p53 sufficient
to activate pro-apoptotic effects of p53. Defining the differences in pharmacologic effect when targeting distinct
types of regulatory circuits (e.g., positively cooperative signaling networks vs. negative feedback transcriptional
networks) represents a key innovation of the planned project. The specific Aims of the project are:
Aim 1: Develop a PK→PD→efficacy model for BI-907828 monotherapy in GBM PDXs
Aim 2: Conduct a phase 0 trial to evaluate the distribution and pharmacodynamics of BI-907828 in GBM
Aim 3: Determine the tolerability of BI-907828 combined with radiation in patients with newly diagnosed GBM
Aim 4: Evaluate combinatorial strategies for BI-907828 with other anticancer therapies for GBM